Identifying imaging biomarkers of cognitive impairment in autoimmune encephalitis

Project Summary
Autoimmune limbic encephalitis (ALE) is an autoimmune disorder that involves inflammation of the brain,
specifically the limbic region that processes memory. It is increasingly encountered by neurologists due to
greater prevalence, recognition and diagnostics. It can be treated with immunosuppressive agents which
improve acute symptoms of confusion and seizures. However, over the long-term, despite initial general
improvement in severe symptoms, many patients do not fully recover and continue to experience residual
symptoms, particularly impacting their cognition.
Due to these chronic cognitive symptoms, many clinicians are faced with the dilemma of whether to continue
immunosuppression or not. This is because it is unclear whether the basis of these cognitive symptoms are
immune mediated or are due to structural or functional changes in the brain.
Many patients with AE have normal appearing conventional brain MRI’s. We currently do not have good MRI
biomarkers that demonstrate the changes that occur in people with ALE compared to healthy controls. We also
do not know whether there are MRI biomarkers that associate with cognitive impairment in people with AE.
There is a need to investigate whether novel MRI techniques can be identified that associate with cognitive
impairment in AE.
In MS and Alzheimer’s disease, novel MRI techniques such as diffusion tensor imaging (DTI) and resting state
MRI (rs-fMRI) provide useful information about the structure and function of the brain, that is not visible on
conventional MRI. These changes have been associated with cognitive impairment in these disorders. We
anticipate that by using these novel MRI methods, we will identify structural and functional abnormalities that
associate with cognitive impairment (specifically memory) and will provide insights into the basis of longitudinal
cognitive impairment.
This study leverages the existing strengths of the Cleveland Clinic including the large longitudinal cohort of
patients with autoimmune encephalitis from which to recruit from. We have the infrastructure for advanced 7T
MRI capabilities and translation research expertise with DTI and rs-fMRI. Finally, we have a robust healthy
control cohort from the Cleveland Clinic brain study who are undergoing 7T MRI and neuropsychological
testing as part of the study. This data will be available for a comparison.
This study will be pivotal in understanding long-term cognitive outcomes in autoimmune encephalitis and the
structural and functional features of this.

Public health relevance
Project Narrative This study aims to investigate the basis of long-term cognitive impairment (predominantly memory) in autoimmune encephalitis and the novel imaging features (diffusion tensor imaging and resting state functional MRI) associated with this.